CSHL Conference on Germ Cells

Project Summary
The germ line is the cell lineage that gives rise to gametes and as such is of substantial practical and
scholarly significance. Germ cells can constitute a source of stem cells for tissue replacement, and understanding
their development is relevant for fertility and reproduction issues. Thus, in addition to the interest at the level of the
basic science, knowledge of germline biology is applicable for medicine and agriculture. Recent major advances in
the field were made in different model organisms and in human making it critical that researchers from diverse
arenas be brought together to share and discuss their discoveries.
This proposal seeks support for the twelfth, thirteenth and fourteenth of a biennial series of meetings held
at Cold Spring Harbor Laboratory that is the premiere meeting for this field. The 2020 Germ Cells meeting will be
held on September 29th-October 3rd and based on the attendance at previous meetings we expect to 250-300
participants from around the world. There are no competing similar forums for all aspects of germ cell research.
Broad topics for platform presentations include the molecular mechanisms controlling germ cell
specification and the control over the germ-cell fate, germ cell differentiation into gametes, germline stem cells,
meiosis, epigenetics, and presentations relevant for the human germline. The sessions will be chaired by experts
in the corresponding fields, providing young scientists with the opportunity to present their work. In addition, very
short “flash talks” will provide the participants with highlights from the poster sessions. Ample opportunity for
informal interactions will also be ensured.

Public health relevance
Project Narrative Animals and plants are composed of somatic cells that form the body, and germ cells that transmit genetic material to the next generation via the union of egg and sperm. This international conference will cover the latest research in germline biology in a range of organisms and experimental systems. By focusing on emerging topics in germline specification, the development of germ cells, gamete formation, fertilization and egg to embryo transition, the meeting will provide unique opportunities for sharing results and for fostering collaborations. The knowledge presented should positively impact the study of gene transmission and reproduction as relevant for human health and breeding of animals and plants.